Accelerating Community-Driven Medical Innovation with VTK

Abstract
Tens of thousands of medical researchers and practitioners around the world use VTK—the Visualization
Toolkit—an open source, freely available software development toolkit providing advanced 3D interactive
visualization, image processing and data analytics algorithms. They either use VTK directly in their in-house
research applications or indirectly via one of the multitude of medical image analysis and bioinformatics
applications that is built using VTK: 3D Slicer, Osirix, BioImageXD, MedINRIA, SCIRun, ParaView, and others.
Furthermore, VTK also provides 3D visualizations for clinical applications such as BrainLAB’s VectorVision
surgical guidance system and Zimmer’s prosthesis design and evaluation platform. VTK is currently accessed
at a rate of more than 2.5 million/downloads per year, and remains a vital system even thirty years after its
initial release in 1993. Considering its broad distribution and prevalent use, it can be argued that VTK has had
a greater impact on medical research, and patient care, than any other open-source medical computing
package.
This proposal is in response to the multitude of requests we have been receiving from the VTK medical and
biomedical computing communities. The aims of this work are as follows:
Aim 1: Ubiquitous Visual Analytics: Establish an easy-to-use workflow so that users and developers
can write VTK-based data analytics tools that are automatically transformed into portable, cross-platform
executable modules. These modules–written just once–can then be used in a portable manner on any
computing platform (desktop, cloud and web-based) and imported into applications.
Aim 2: AI-Ready Visualization: Extend VTK’s current support of AR/VR to integrate AI into immersive
workflows such as surgical and point-of-care applications. Provide visualization techniques, including saliency
maps and Grad-CAM, to build trust in and validate AI workflows. Employ AI to drive the data transformation
and rendering processes such as adaptively configuring transfer functions to highlight and efficiently convey
clinically important information.
Aim 3: Enhanced Community Support: Enable users and developers to more rapidly learn about,
develop code for, and deliver VTK-based visual analytics applications. Using open-source LLM AI /ML models,
train these models on the decades of community resources and millions of lines of VTK source code to provide
rapid collation of relevant information, and enable the generation of programming extracts to accelerate the
creation of specialized workflows.

Public health relevance
Project Narrative The Visualization Toolkit (VTK) is an open source, freely available software library for the processing, visualization, and analysis of medical and biological data; used around the world in medical research applications such as 3D Slicer and Osirix, and in several commercial medical applications, such as BrainLAB’s VectorVision surgical guidance system. With recent improvements to AI and web software tools, VTK will be greatly enhanced so that data tools can be deployed as desktop, cloud, and web applications without the need for code rewrite; also providing support for AI chatbots with associated tools for explainable AI such as saliency maps. With the proposed improvements, not only will existing applications continue to provide advanced healthcare, but new, innovative medical applications will be inspired and available across computing environments.